Selective Functionalization of Aliphatic Amines

Principal Investigator/Program Director (Last, First, Middle): Rovis, Tomislav
Selective Functionalization of Aliphatic Amines – Supplement Request Summary
This is a Supplement Request to replace a key piece of equipment that facilitates our NIGMS funded
research program entitled “Selective Functionalization of Aliphatic Amines”. Our inert atmosphere
glove box that facilitates reaction set-up, analysis and mechanistic investigations is routinely failing
due to age and use. Funds are requested that we may continue our work under both solvent-less and
solvent-capable conditions.
PHS 398/2590 (Rev. 09/04) Page Continuation Format Page

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): Rovis, Tomislav Selective Functionalization of Aliphatic Amines – Supplement Request Project Narrative This is a Supplement Request to replace a key piece of equipment that facilitates our NIGMS funded research program entitled “Selective Functionalization of Aliphatic Amines”. Advances in health related research need specialized equipment to accelerate the pace of discovery. Equipment that is heavily used has a finite lifetime. We seek funds to replace one such key piece of equipment. PHS 398/2590 (Rev. 09/04) Page Continuation Format Page